Bio-Click: A cell-free high-throughput platform for the engineering of enzymatic group transfer reactions

Project Abstract – Invizyne Technologies, Inc
Biocatalytic group transfer reactions are essential in all biological systems and have
emerged as powerful tools in synthetic biology and cell-free biomanufacturing. Their
characteristics and mechanisms bear striking similarity to click chemistry reactions (‘BioClick
Reactions’) and their ability to regio- and stereo-specifically modulate natural products and
synthetic pharmaceuticals can dramatically improve physiochemical, biological, and
pharmacological properties of molecules.
We propose a novel cell-free, high-throughput platform to expedite the engineering of
enzymes for BioClick reactions. Our platform integrates cell-free protein synthesis (CFPS) with
multiplexed mass spectrometry for rapid screening of vast enzyme variant libraries against
diverse substrate pairings.
Invizyne has developed the cell-free biochemistry pipeline SimplePath™ which can
produce cofactors for a variety of BioClick reactions at low cost. Phase I of this project focuses
on our most mature technology – the biocatalytic prenylation of aromatic pharmaceutical and
nutraceutical scaffolds using our workhorse enzyme NphBM34S. Our project pursues two primary
aims: i) establishing an in-house CFPS system for efficient and rapid expression of site-saturation
libraries of NphBM34S variants and ii) utilizing low-cost prenyl-donors to screen variant libraries
against a collection of prenyl-acceptor substrates using robotics and high-throughput
experimentation (HTE), and subsequently analyzing results with multiplexed mass spectrometry
and cloud-based computational tools for data deconvolution.
Successful completion will establish a rapid and efficient platform for BioClick reaction
engineering, identify promising NphBM34S variants for diverse prenylation reactions, and
validate the utility of CFPS and HTE for BioClick reaction discovery. This not only paves the way
for AI-based protein engineering and natural product development during Phase II of this
project but may also offer a transformative strategy for ‘Generative Biocatalysis’ with potential
applications across drug discovery, combinatorial medicinal (bio)chemistry and natural product
synthesis.

Public health relevance
Project Narrative – Invizyne Technologies, Inc Enzymatic group-transfer reactions are biological click reactions that bear immense potential in drug development and biomanufacturing of active pharma- and nutraceutical ingredients as they are capable of greatly altering the pharmacological properties by orders of magnitude. While many of these group transfers are difficult to achieve chemically, nature evolved a plethora of enzyme capable of BioClick reactions and Invizyne’s cell-free approach is harnessing this power of nature for the discovery and industrial production of medically relevant molecules. Completion of this Phase I SBIR focuses on the development of the BioClick Screening Platform, a deployment-ready cell-free, high-throughput experimentation platform to expedite the enzyme engineering and biocatalytic reaction design of biochemical group-transfers.